Consumer-Therapist-Connector: Increasing Access to Quality Behavioral Healthcare

ABSTRACT
The United States is experiencing a major mental health crisis that persists post-pandemic. Per
recent media reports, the gap between need and access to behavioral health services is rapidly
increasing. There is an urgent need to solve both the access and quality problems with
behavioral healthcare. One study found that 76% of surveyed employees are reporting at least
one significant behavioral health symptom. Another report indicated that adults are on waitlists
for 3+ months to receive outpatient therapy in Massachusetts. There simply are not enough
therapists to meet the increasing demand and waitlists are long and growing. On the quality
side, more than 60% of patients find no meaningful benefit from the treatment they receive. We
have already created an innovative system called TOP Match that improved the quality problem
in a randomized clinical trial: matching to therapists’ measurement-based and problem-specific
strengths roughly doubled patient improvement levels, relative to usual case-assignment
methods. In this proposal, we simultaneously aim to solve the access problem by finalizing,
customizing, and testing our next innovation: Express Access. The Phase I feasibility tests of
Express Access were successful: Focus groups conducted with multiple stakeholder groups
(patients, therapists, and staff) identified key themes about content and functionality (e.g.,
scheduling, preferences, features) to incorporate into the prototype (Aim 1). Their input informed
the development of two interactive prototype flows: one for patients and one for staff (Aim 2).
The prototype received usability and acceptance ratings that exceeded the feasibility criteria
(Aim 3) and generated valuable input to be used during Phase II design and development. This
proposed online system, Express Access, will expeditiously connect patients who are seeking
behavioral health referrals from their Primary Care Physicians with well-matched therapists for
traditional therapy by distance search, or telemedicine by state or national searches. What
distinguishes our solution from other online find-a-therapist systems is that patients can instantly
add themselves to the waitlist of all empirically well-matched providers, encouraging consumers
and providers to offer and accept appointments when a match is likely to greatly benefit the
patient, thus increasing the likelihood patients will connect quickly with a good-fitting therapist.
To achieve our Phase II Aims to develop and test Express Access, we have engaged two key
clinical partners: Grow Therapy, one of the largest national providers of behavioral healthcare,
and the American Academy of Family Physicians (AAFP), the largest association of primary
care physicians to work with us.

Public health relevance
PROJECT NARRATIVE We propose to develop and test an innovative system called Express Access to facilitate behavioral health referrals from primary care physicians (PCPs) to the therapists who have had patients with successful therapeutic outcomes in the patients’ specific area(s) of need. Waitlists, while frustrating, are unavoidable in the current marketplace given serious supply and demand inequities for behavioral health care. Within this new flexible, secure, online system, we will reduce the administrative burden on vulnerable patients and overbooked therapists, while maximizing therapy access and quality.